The role of VAMP2 in alpha-synuclein function and pathology

PROJECT SUMMARY
α-Synuclein (α-Syn) is a protein abundantly distributed in presynaptic terminals. α-Syn pathology is linked to
synucleinopathies including Parkinson’s disease (PD) and Lewy body dementia, and α-Syn missense muta-
tions cause early onset PD. Physiologically, α-Syn functions in synaptic transmission via clustering synaptic
vesicles (SVs) and promoting SNARE-complex assembly. This function strongly depends on binding to SVs.
Pathologically, levels of vesicle-associated membrane protein 2 (VAMP2) and functional monomeric α-Syn
simultaneously decrease with increasing duration of dementia, which implies a potential functional link between
VAMP2 and normal monomeric α-Syn. Preliminary data showed VAMP2 interacts with α-Syn to prevent α-Syn
aggregation. The long-term goal of this project is to define and characterize critical protein factors that stabilize
binding of α-Syn on SVs and test their effect on neuron function and α-Syn induced toxicity. The central hy-
pothesis is that VAMP2 stabilizes α-Syn in its functional conformation on SVs to mediate vesicle clustering and
SNARE-complex assembly, and to prevent pathological aggregation. Guided by strong preliminary data, this
hypothesis will be tested in three specific aims: 1) Determine how VAMP2 prevents α-Syn aggregation and
toxicity; 2) Determine α-Syn’s function in SNARE-mediated fusion in vitro; 3) Determine the influence of
VAMP2 on α-Syn’s function and toxicity in vivo. Under the first aim, α-Syn interaction with VAMP2, folding and
oligomerization will be analyzed in solution and on membranes, using NMR, ThioflavinT, CD, FRET and solid-
state nanopore experiments on recombinant α-Syn variants. Under the second aim, the mechanism and kinet-
ics of SNARE-mediated membrane fusion will be analyzed, using single-molecule fusion, vesicle clustering and
NMR experiments on recombinant α-Syn variants. Under the third aim, localization, function, and aggregation
of α-Syn variants will be analyzed, using biochemical and cell biological assays on primary mouse neurons, in
addition to behavioral and pathology readouts in wild-type and heterozygous VAMP2 mice. The study is ex-
pected to show improved function and reduced toxicity of α-Syn with increased SV binding. This research is
significant because it will (1) clarify the importance of SV binding of α-Syn for SNARE-complex assembly and
neuron function, (2) provide novel insights into the function/dysfunction of recently identified PD-mutations of α-
Syn, (3) provide new insights into the molecular mechanism underlying SV-binding of α-Syn by altering VAMP2
levels, and has (4) translational importance for the targeted development of new strategies aimed at preserving
α-Syn’s function via stabilizing its SV-bound pool through elevating VAMP2 levels. Our study is innovative be-
cause it (1) uses a multidisciplinary approach combining biophysical, biochemical, and cell biological ap-
proaches, (2) uses unique single-particle detection assays to study α-Syn function and early oligomerization,
and (3) tests the novel hypothesis that VAMP2 is important stabilizers of SV-binding of α-Syn and that stabili-
zation of the SV-bound pool of α-Syn prevents its aggregation and toxicity.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because alpha-synuclein pathology is linked to various neurological diseases including Parkinson’s disease and Lewy body dementia, and understanding the underlying disease mechanisms will allow us to develop a novel intervention therapy. Thus, this research is relevant to the NIH’s mission that pertains to supporting the ongoing basic research, foster research that has immediate medical relevance, and encourage translational research that links the discoveries from basic research into therapeutic interventions for treating neurological disorders such as Parkinson’s disease and Lewy body dementia.